Financial assistance for low-income Medicare beneficiaries: Using natural experiments to assess effects on care and health outcomes

PROJECT SUMMARY / ABSTRACT
This AHRQ Mentored Research Scientist Career Development Award (K01) for Dr. Eric T. Roberts, an
assistant professor of health policy and management at the University of Pittsburgh Graduate School of Public
Health, will establish Dr. Roberts as a health economist with expertise in health insurance and health care
policy for aging and low-income populations.
Research proposed for this K01 award will harness natural experiments created by eligibility thresholds
and policy variation within Medicare subsidy programs to rigorously evaluate how these programs affect
patients' use of care, access to providers, and health. This project will focus on two subsidy programs for
low-income Medicare beneficiaries: the Medicare Savings Programs (MSPs), which are partial Medicaid
benefits that defray out-of-pocket costs for physician services and inpatient care, and the Part D Low-Income
Subsidy (LIS), which helps to pay for prescription drugs. Using the Health and Retirement Study linked to
Medicare and Medicaid claims, Dr. Roberts will examine how discontinuities in subsidy eligibility affect
patients' use of care—including medication adherence, physician visits, and hospitalizations—and health
status. Dr. Roberts will also examine the relationship between state Medicaid policies—specifically, provider
payment rates and rules for recertifying program eligibility—with MSP enrollment and patients' access to
care. Evidence generated from this research can guide reforms to increase the benefits of the MSPs and LIS
to low-income Medicare beneficiaries and to the Medicare program.
This project draws on Dr. Roberts' quantitative training, knowledge of Medicare and Medicaid policy, and
prior research on health disparities. This work will extend Dr. Roberts' scholarship into the field of aging while
incorporating methods in pharmaceutical health services research. Therefore, for this K01 award, Dr. Roberts
will engage in training and career development activities that focus on acquiring expertise in aging and
pharmaceutical health services research. Through mentorship from health services researchers and clinical
experts, Dr. Roberts will also focus on applying training in these content areas to health policy research. This
training plan complements the proposed research and will equip Dr. Roberts to establish an independent
research program examining policy innovations to improve care for low-income Medicare beneficiaries,
quantifying the clinical and economic impacts of policy reforms for patients, payers, and health systems.

Public health relevance
PROJECT NARRATIVE The Medicare Savings Programs and the Part D Low-Income Subsidy are financial assistance programs that help pay for low-income Medicare beneficiaries' premiums, deductibles, and cost sharing for physician services, hospital care, and prescription drugs. Harnessing quasi-experimental variation in the design of these subsidies and in state policies, this project will provide policy makers with evidence about how subsidy programs affect low-income patients' use of care and health, and elucidate the role that state policies play in facilitating patients' access to care and retention of subsidies. Findings from this project can inform policies to improve the structure of subsidy programs for vulnerable older Americans, addressing public health priorities of improving access to care and reducing health disparities in this patient population.